Tumor Biology Program

The Tumor Biology Program has witnessed growth in intra-programmatic and inter-programmatic efforts, both in terms of collaborative research and joint publications. Four thematic or affinity research groups have been spawned, unified by research meetings and symposia. Apart from consideration of other new thematic groups, the Program is working towards new interdisciplinary grants to the NIH and other sources.